Structural and functional characterization of ATP synthase c-subunit leak channel and its role in AD pathogenesis

Abstract
Mitochondrial and synaptic dysfunction are early pathological features and a driving force of
Alzheimer's disease (AD) pathology. Aβ is found to accumulate abnormally in the brains of AD
individuals and in an AD mouse models leading to mitochondrial Ca2+ overload and activation of
mitochondrial permeability transition pore (mPTP). Prolonged opening of mPTP triggers outer
mitochondrial membrane rupture, release of cytochrome c and activation of downstream cell
death pathways. The mPTP has been at the center of extensive scientific research for the last
several decades but it still remains as one of the most mysterious phenomena in biology today
due to its controversial molecular composition and the lack of structural information of its pore.
We have recently demonstrated the novel role of ATP synthase c-subunit ring in forming the
channel of mPTP. Nevertheless, the gating mechanism of the ATP synthase c-subunit leak
channel and conformational changes initiating its opening are yet to be discovered.
In this proposal, we will use single-particle cryo-electron microscopy (cryo-EM) to identify the high-
resolution structure and the open conformation of ATP synthase leak channel in the presence of
channel modulators. We will also perform in situ structural analysis of ATP synthase in its
functional environment within the Aβ-exposed primary hippocampal neurons and in mitochondria
isolated from the mouse models of AD by using cryo-electron tomography (cryo-ET). In this project
we will also investigate the direct role of ATP synthase leak channel as a novel cell death pathway
in AD pathogenesis; we will test whether the pharmacological inhibition of this channel will rescue
neurons from Aβ-induced cell death. Successful completion of this proposal will reveal the
molecular mechanism(s) of mitochondrial permeability transition, the atomic structure of ATP
synthase leak channel, and will aid in the development of new treatments for AD, targeting ATP
synthase.

Public health relevance
Project Narrative Mitochondrial permeability transition is a key event in the induction of cell death during the progression of neurodegenerative disease. This project will determine the single-particle cryo-EM structure of ATP synthase c-subunit leak channel that houses the pore of the mitochondrial permeability transition. The successful completion of the proposed project will result in novel therapies and preventative strategies for Alzheimer's disease by targeting the ATP synthase leak channel.